Core 3: Chemical Biology & Materials Tools (CBMT)

Project Summary
Chemical Biology tools for probing, manipulating, and imaging biological systems can provide
deep insights into fundamental processes. Chemical dimerization and protein localization
strategies, fluorescent probes and sensors for analyte detection, and small molecules for
perturbing biological pathways and process have become important research tools for gleaning
deeper insight into biological processes. The development of optically triggered variants of these
important chemical biology tools has provided new and more powerful approaches to probing,
manipulating, and imaging key pathways and processes with new levels of spatial and temporal
control not previously available. Despite the utility of molecular chemical biology approaches,
many of the tools and reagents are not readily available due to the need for on-demand synthesis
and molecular customization depending on the pathways and processes being studied and the
lack of commercially availability. The proposed Chemical Biology and Materials Core will solve
these problems by working directly with the individual projects of the program to design,
synthesize, and implement cutting edge Chemical biology tools customized to the project
research aims. The Chemical Biology Core will also serve as a resource throughout the award
period to develop new approaches and implement key technologies in synergy with the MAC core
and individual projects. In Aim 1 the core will develop chemical dimerizers for optogenetic control
of key biomolecule localization and activation events. In Aim 2 the core will develop peptide based
chemical probes for interrogation of key biological pathways and processes.

Public health relevance
Project Narrative Chemical Biology tools for probing, manipulating, and imaging biological systems can provide deep insights into fundamental processes. Protein chemical dimerization tools, peptide chemical tools, and small molecule agonist/antagonist chemical tools are critical to key project Aims in this P01. The Chemical Biology and Materials Core will work directly with the individual projects in this program to design, synthesize, and implement cutting edge Chemical biology tools customized to the project research aims.